Aurin Tricarboxylic Acid (ATA) as a Potential Radionuclide Decorporation Agent

To determine if ATA, a molecule with metal chelating properties, will bind ingested cesium (Cs), an internalized radiological threat, making it a promising decorporation agent.